SCH: Machine learning for personalized preventative intervention in perinatal depression

PROJECT SUMMARY (See instructions}:
The goal for this project is to develop machine learning (ML) to accelerate the discovery of scalable,
interpretable, and personalized preventative interventions for perinatal depression. Approximately 15% of
pregnant individuals experience perinatal depression, which can have devastating long-term
consequences. Suicide is a leading cause of death among new mothers in the U.S. However,
individualized preventive interventions are not routinely offered at present due to lack of routine screening
practices and limited resources. Machine learning offers an opportunity to improve mental health services
during the perinatal period by identifying patients who would benefit from specific preventative
interventions. We will develop fundamental advances in ML techniques for the discovery of personalized
interventions as well as advances in the social science of incorporating domain and lived experience into
algorithmic systems. Our specific aims bridge prediction with the adaptive experimentation needed to
identify personalized interventions. In Aim 1, we will develop methods which use existing historical data to
lay the groundwork for a randomized experiment of interventions, including to robustly inform which
variables to measure and how to set an initial allocation policy based on those variables. In Aim 2, we will
elicit domain expertise from clinicians and lived experience expertise from perinatal individuals via semistructured
interviews which will inform both the requirements for a trustworthy and implementable ML
system and a structured representation of clinical expertise that can be incorporated to initialize a ML policy
together with historical data. Finally, in Aim 3, we will synthesize these products into an integrated
framework for online learning to discover personalized preventative interventions. The key component of
this framework is continued interaction with patients to provide intermediate feedback and accelerate
convergence to a high-quality policy for allocating preventative interventions.

Public health relevance
RELEVANCE (See instructions}: Depression is one of the most common complications of pregnancy and there are interventions that can help treat or even prevent depression symptoms among pregnant people. The earlier individuals start such preventive care, the sooner it can work, but there are often limited numbers of mental health care providers available, and it is not yet known which treatments work best for which patients. This research will help tailor treatment approaches to proactively prevent depression before it starts.